Development of a standardized measure of social-communication abilities for children with neurodevelopmental disorders

PROJECT SUMMARY
Summary has not changed for this Administrative Supplement.

Public health relevance
PROJECT NARRATIVE Narrative has not changed for this Administrative Supplement.